Orbitrap Exploris 480 Mass Spectrometer for Biomedical Research

Abstract
This grant application requests funds to purchase a Thermo Scientific Orbitrap Exploris 480 and UltiMate 3000
RSLCnano HPLC, and FAIMS (high field asymmetric ion mobility spectrometry) interface for shared use in the
Institutional Mass Spectrometry Laboratory (MSL) at the University of Texas Health Science Center at San
Antonio (UTHSCSA), directed by Dr. Susan Weintraub. The requested system will provide enhanced capabilities
and expanded capacity for protein identification and relative quantification as well as valuable information for
structure determination of proteins and protein complexes. Project summaries for 14 investigators are presented,
with major focus on cancer and infectious disease (HIV, TB and SARS-CoV-2). The global proteomics
experiments proposed by the user group will be conducted by data-independent acquisition mass spectrometry
(DIA-MS). Use of this technique in the MSL over the past three years has demonstrated its extraordinary
capabilities for comprehensive protein identification with greater accuracy for relative quantification, in an efficient
and remarkedly reproducible manner. DIA-MS is being used in the MSL for numerous studies requiring discovery
proteomics [including analysis of proteins from cells, tissues, secretomes, alveolar lining fluid (ALF)] and for
interactomics. Cross-linking-MS is a new service that will be offered by the MSL; it will be an important partner
for protein structure analyses conducted by cryo-electron microscopy in the new UTHSCSA facility that will open
in spring 2022. In 2020, the user group of the MSL submitting samples for protein/peptide analysis consisted of
27 individual investigators in 17 departments at UTHSCSA in addition to 11 researchers from nine different
outside institutions. Submissions to the MSL for protein identification/relative quantification dramatically
increased when investigators became aware of the incredible power of DIA-MS. This resulted in a progressively
growing backlog of DIA-MS samples. The level of interest in DIA-MS is evidenced by the support letters written
for grant applications by Dr. Weintraub: >70% of the 35 letters written in 2020 discussed DIA-MS experiments
(in most cases as the only MS-based technique being planned). DIA-MS analyses are currently being conducted
on a Thermo Scientific Orbitrap Fusion Lumos mass spectrometer, yielding previously unprecedented numbers
(>5,000) of protein identifications and relative quantifications for single injections of cell lysate samples. Results
acquired in the Thermo “demo” lab showed that the requested Exploris outperformed the Lumos for DIA-MS
analysis of aliquots of the same samples (6,665 vs 5,248 proteins). Acquisition of the requested Exploris is
essential to handle the rapidly-expanding submissions and increasing backlog for DIA-MS in the MSL as well as
to provide new capabilities for protein/protein complex structure analysis via cross-linking-MS. The analytical
support that will be provided by the Exploris 480 and FAIMS interface will significantly advance the productivity
of a large number of NIH-funded investigators studying important and diverse problems in biomedical research.

Public health relevance
Project Narrative Acquisition of the requested Exploris 480 mass spectrometer and accessories will advance the research efforts of a large number of investigators who study a wide range of biomedically-relevant problems. The projects described in the proposal focus on cancer and infectious disease [HIV, TB and SARS-CoV-2 (COVID-19)]. The Exploris 480 has extraordinary capabilities for efficient and accurate determination of protein identities and relative quantities (>6,000 proteins identified in a single analysis), providing critically-important information about biological processes as a way to understand mechanisms of disease development and progression, contributing to the discovery of new, more effective drug treatments.